Structural biology of chromatin in vitro and in cells

Project Summary
The laboratory led by PI Galia Debelouchina has the following objectives: 1) The development of structural
biology methodology to study complex and dynamic biological assemblies in vitro, and 2) The extension of
these methodologies for structural biology investigations in the cellular environment. Our methodology
development combines solid-state nuclear magnetic resonance (NMR) spectroscopy with state-of-the-art
chemical biology tools for the comprehensive description of biological systems both in vitro and in cells. We
use these technologies to investigate chromatin, a complex protein-DNA polymer responsible for the
packaging of genetic information in the nucleus. Over the next five years, we plan to focus on the following
projects: 1) The influence of protein post-translational modifications on chromatin structure and dynamics.
Modifications such as methylation and acetylation have profound effects on the compaction of the chromatin
polymer and the accessibility of the packaged DNA. We plan to investigate the molecular mechanisms of
chromatin compaction and decompaction imparted by these modifications at atomic resolution using solid-state
NMR spectroscopy. We expect that this study will provide unique insights into the biophysical properties of the
chromatin polymer and how they can be translated into functional biological outputs. 2) The molecular basis of
heterochromatin formation. Heterochromatin compartments are associated with gene silencing and repetitive
DNA sequences, and their formation is a vital step in cell differentiation and development. Recent hypotheses
indicate that they are formed through liquid-liquid phase separation. We plan to investigate the interactions that
promote phase separation and to provide the first molecular description of this process. 3) Development of
NMR-based tools for structural biology in cells. Here, we plan to focus on the design and implementation of a
strategy to target a specific protein in the cellular milieu and to increase its NMR signals selectively over the
cellular background. Ultimately, we aim to develop a selective and sensitive NMR methodology that will allow
us to record relevant structural data of endogenous amounts of cellular proteins. Such tools will provide the
unprecedented opportunity to build an atomic resolution picture of the cellular milieu and to investigate
changes in protein structure and dynamics as we stress, age or treat cells with therapeutic agents.

Public health relevance
Project narrative Each cell in the human body contains two meters of DNA that need to be packaged in the tiny micrometer- sized cellular nucleus. This proposal describes new methodologies that can be used to study this process both in vitro and in cells. Understanding the mechanisms of DNA packaging will shed light on normal cell differentiation and development and on the molecular origins of disease such as cancer.